The effect of SHANK3 mutation in transgenic prairie voles on natural social behaviors and genetic mechanisms

Project Summary
Autism spectrum disorder (ASD) is a cluster of related neurodevelopmental disorders that collectively impact 1
in 54 children in the United States. Shank3 is an ASD-associated gene because of evidence linking human
Shank3 dysfunction to ASD and due to ASD-related behaviors caused by Shank3 mutations in two mouse
lines. Shank3 mutant mice have multiple neuronal deficiencies in the striatum (altered synaptic structure and
function, dendritic spine hypertrophy, corticostriatal hyperconnectivity, and enlarged striatal volume) and
transcriptome in the striatum suggests additional dysregulation in glutamate-related and kinase-related genes.
Research on how the Shank3 mutation affects ASD or social behavior more broadly is currently limited by the
focus on a single inbred mouse species. The recent availability of a Shank3 mutant prairie vole represents a
critical advance because, unlike mice, prairie voles are genetically diverse, share complex social behaviors
with humans (monogamous pair bonding, bi-parental care, social loss-induced depression, and empathy-
based consoling), and the full spectrum of social behaviors can be quantified in free-living prairie voles under
natural conditions. The objective of this proposal is to determine the effects of Shank3 mutation in prairie voles
on complex social behaviors in the field and laboratory, and the underlying biological mechanisms in the brain.
Our central hypothesis is that Shank3 mutation in prairie voles alters striatal transcription regulating social
behavior, which interacts with genotype to change both naturally observed and laboratory-induced species-
specific complex social behaviors that are relevant to autism. Specific Aim 1 will determine the changes in
natural social behaviors caused by Shank3 mutation. We will track social and reproductive behavior of free-
living Shank3 mutant and wild-type prairie voles in semi-natural field enclosures over 3.5 months using an
automated behavioral monitoring system, video cameras, and social network analyses. Specific Aim 2 will
determine and integrate the transcriptome, genome and behavior of Shank3 mutant voles. We will test
laboratory voles on a behavioral battery of their unique species-specific social behaviors, and then sequence
the transcriptome and genome from dissected striatum. We will combine the three data sets using multi-omic
integration. Together, this will provide critical information regarding the molecular and cellular alterations
caused by Shank3 mutation, which will be directly relevant to potential clinical treatments and therapies. The
proposed research will also validate the most recent innovation in transgenic prairie voles as a model for
Shank3-related autism research.

Public health relevance
Project Narrative The Shank3 gene is a prominent autism-associated gene, both because of evidence linking human Shank3 dysfunction to ASD and 22q13 deletion syndrome, and due to autism-related behaviors caused by Shank3 mutations in two mouse lines. Here, we propose to use a new outbred transgenic animal, the Shank3 knock- out prairie vole, to explore the genetic mechanisms relating Shank3 deletion to autism-relevant behavior in ways not previously possible in laboratory mice, including the use of species-specific complex social behaviors, semi-natural outdoor enclosures, and natural genetic diversity. We will leverage this innovation to find new autism-relevant connections between genome, transcriptome, Shank3 mutation, laboratory behavior and semi- natural behavior that suggest new avenues of research and possible treatments.